Expanding the efficacy of asparaginase to solid tumors

The goal of this proposal is to provide in vivo proof-of-concept for the use of the blood cancer drug
asparaginase (ASNase) in hepatocellular carcinoma (HCC) patients who possess the biomarkers for response
to this novel biologic. ASNases have a unique mode of action wherein the drug depletes the amino acid
asparagine from the blood, and, as a result, cells that rely on blood asparagine are starved and ultimately
killed. The current FDA-approved ASNases are of bacterial origin, which makes them immunogenic, and their
toxicity-causing glutaminase (GLNase) side activity causes severe drug side effects, which are exacerbated in
adults. Therefore, despite the immense potential of ASNases for the treatment of several cancer types, these
drugs are predominately confined to the treatment of pediatric acute lymphoblastic leukemia (ALL). To make
ASNase therapy an option for adult patients with cancers that depend on blood asparagine, we engineered a
human-like ASNase that mitigates the immune response and is highly specific to eliminate the GLNase-related
toxicity. Notably, toxicity studies comparing our engineered human-like ASNase to the current standard-of-care
bacterial ASNase (Oncaspar) demonstrated the significantly improved safety of our ASNase. Importantly, the
improved safety comes with equivalent efficacy for ALL. Together, these developments make it possible to
expand ASNase therapy to solid tumors in adult cancer patients. Response to ASNase is dependent on no/low
expression of the enzyme that synthesizes asparagine de novo, called asparagine synthetase (ASNS).
However, a durable response requires the inability of the cancer cell to upregulate ASNS expression in
response to asparagine depletion. The ability to upregulate ASNS expression is determined by the methylation
state of the ASNS promoter, where hypermethylation prevents expression and hypomethylation allows for
expression. Recent analysis of cancer cell lines and patient samples reveal that many HCC patients possess
either the full ASNase-response signature (low ASNS levels, hypermethylated promoter) or partial ASNase-
response signature (low ASNS levels, hypomethylated promoter). Tumor cells with the full signature are
predicted to strongly respond to ASNase alone, and those with the partial signature are predicted to have a
less durable response. In preliminary work, we verified the predictive power of the full and partial ASNase
response signatures on several HCC cell lines. To increase the clinical relevance of this observation, in Aim 1
we will collect HCC tumor samples from Veterans (treated at JBVAMC) and from a predominantly minority
population (treated at UIC) and determine the predisposition of these patients to possess the ASNase-
sensitivity biomarkers. These patient samples will also be used to generate HCC primary cell line, organoid,
and PDX models. In Aim 2, using both in vitro and in vivo studies, we will determine the factor(s) that make
HCC cell lines sensitive or resistant to ASNase therapy. Aim 3 will expand the in vivo studies to the patient-
derived cell lines, organoids and PDXs generated in Aim 1, and evaluate our ability to predict which patients
will respond to ASNase therapy. Success in these studies will supply the proof-of-concept for using our new,
safer ASNase in HCC. Moreover, by utilizing mechanistically based biomarkers we would be able to identify
those patients that would respond to ASNase. Success will also provide the impetus for testing this novel
approach in other cancers, using the biomarkers validated by these studies for patient selection.

Public health relevance
L-asparaginase (ASNase) is a biological cancer drug with a unique mode of action, with broad potential use, although it currently is mostly limited to a childhood blood cancer called ALL because the side effects are exacerbated in adults. Our previous work designed and evaluated a new ASNase, predicted to be much better tolerated by adult cancer patients, thus creating multiple potential additional uses beyond ALL. We now also better understand which patients would respond to this drug, allowing us to employ personalized medicine to identify those cancer patients. In this application, we expand ASNase treatment from blood cancers to solid tumors, where we evaluate the efficacy of ASNase in liver cancer, including studies of factors that can lead to drug resistance. This combination of our new and safer ASNase (which will permit use by the adult VA patient population), with a screen that predicts which patients would benefit most from this treatment, will impact the treatment of Veterans with liver cancer and other solid tumor cancers such as gastric and AML.